Regulation of rodent energy metabolism, body weight and composition

We created a mathematical model of mouse energy metabolism that provides a quantitative framework for investigating energy balance relationships in mouse models of obesity and diabetes. We are now investigating body weight regulation of mice subjected to various ad libitum diets inducing weight gain and loss. We are particularly interested in the role of striatal dopamine signaling in food intake and physical activity behavior and we are studying mice with a knockout of the dopamine type 2 receptor specifically in the striatum.